Associative Processes in Episodic Memory

Project Summary / Abstract
The hallmark feature of episodic memory is the ability to link events with their temporal and situational
contexts. This ability allows for memories to be truly autobiographical. Importantly, models suggest that the fate
of our memories is strongly inﬂuenced by latent reminders, reactivations, and retrievals – processes normally
invisible to the experimenter. The proposed research aims to illuminate the neural and cognitive mechanisms
underlying human episodic (contextually-mediated) memory through both computational modeling and the
analysis of intracranial and scalp electroencephalographic (EEG) recordings taken as neurosurgical patients and
healthy adults undergo virtual reality experiences and then search their memory for material studied therein.
We will use a model-based approach coupled with multivariate pattern analysis applied to electrophysiological
data. Our ﬁrst aim is to elucidate how memory reactivation, driven by repetition of items or their contexts, shapes
subsequent recall and memory organization. We further seek to decode endogenous memory reactivation events
(rehearsal and replay) from neural data, and to determine their inﬂuence on subsequent recall behavior (Aim
2). Finally, we will connect memory retrieval and decision-making processes by investigating how behavioral
and neural retrieval dynamics shape value-based decision making. This work will serve as an important bridge
between the behavioral and neurobiological approaches to human memory.

Public health relevance
Narrative / Relevance One of the longstanding mysteries concerning human memory is how the brain organizes and recalls memories of past experiences. Cognitive theories of memory search and retrieval propose that each memory is encoded into its own unique situational context, that the context of a memory is updated each time we retrieve it, and that this context information guides memory search. The proposed research will combine computational modeling approaches with analysis of direct brain recordings in neurosurgical patients, as well as non-invasive recordings in healthy adults, to bridge these cognitive theories of memory with the neural mechanisms underlying this vital human ability.